ATHEROSCLEROTIC CORONARY ARTERY DISEASE AND INSULIN RESISTANCE

The purpose of this study is to examine the role of hyperinsulinemia and insulin resistance as causative factors in the development of coronary artery disease.